Brain CHEC-AC (Brain and Cognitive Health Equity Campaign for Allegheny County)

Despite being at nearly twice the risk of developing Alzheimer's or a related dementia (ADRD), Americans
identifying as Black or African American are 35% less likely to be diagnosed with ADRD than their White
counterparts. This marked disparity in dementia detection and diagnosis has corresponding implications for
delays in the initiation and continuation of treatment. Intervening to eradicate this disparity is a public health
imperative as the field of ADRD care is on the precipice of a sea change due to newly available disease modifying
therapies. These therapies require testing to confirm the presence of amyloid accumulation, and they must be
initiated in the early stages of cognitive impairment. Under the current paradigm, the vast majority of African
Americans adults for whom these new therapies may be appropriate will be diagnosed too late for their
administration. This proposal recognizes that structural factors shaping daily life, like societal stigma around
brain health disorders, and experiences of discrimination in medical settings, contribute profoundly to disparities
in ADRD detection among African American adults and require multilevel intervention to be dismantled. In
response to NIH RFA-NR-24-004, Transformative Research to Address Health Disparities and Advance Health
Equity, the long-term goal of this project is to address existing, and intercept a worsening of, disparities in early
detection and diagnosis of ADRD. To achieve our goal, we will carry out three primary objectives in partnership
with the Black Equity Coalition and the Allegheny County Health Department. Using the Culture-Centric Model
of Health Promotion, in Objective/Aim 1 we will elicit and prioritize the voices of African American adults who are
directly impacted by late-life cognitive health disparities to create stakeholder-endorsed brain health narrative
campaign materials for deployment over multimedia platforms. In Objective/Aim 2, we will use the materials
developed in Aim 1 to deploy a community-focused brain health narrative campaign to combat stigma around
brain health disorders in the places where African American adults at risk for ADRD live, work, shop, and play.
In Objective/Aim 3, we will assess the feasibility and acceptability of bringing state of the science AD bloodbased
biomarker testing infrastructure to the places where African Americans at highest risk for ADRD live, work,
shop, and play. By targeting social norms and societal level forces like stigma, this proposal addresses
challenges at the NIMHD-defined community and societal levels, while, in the final aim building communitybased
infrastructure for addressing a health disparity at the individual level. This approach begins by drawing
upon cultural capital in the form of community members' stories that demonstrate the value of preserving brain
health or offer counternarratives about maintaining dignity through dementia. In full circle, these stories become
culturally salient tools to promote accessible, early AD detection in community-based settings, bypassing the
traditional healthcare systems and pathways to diagnosis that are not working for African Americans.

Public health relevance
Project Narrative This project will examine how a strategy called storytelling may help to reshape perceptions of brain aging and conditions like dementia. The ultimate goals of this work are to combat harmful misperceptions around dementia that will ultimately promote early detection and diagnosis of dementia among those at highest risk. ABSTRACT Despite being at nearly twice the risk of developing Alzheimer’s or a related dementia (ADRD), Americans identifying as Black or African American are 35% less likely to be diagnosed with ADRD than their White counterparts. This marked difference in dementia detection and diagnosis has corresponding implications for delays in the initiation and continuation of treatment. Intervening to eradicate such delays is a public health imperative as the field of ADRD care is on the precipice of a sea change due to newly available disease modifying therapies. These therapies require testing to confirm the presence of amyloid accumulation, and they must be initiated in the early stages of cognitive impairment. Under the current paradigm, many adults at highest risk for ADRD who could benefit most from these new therapies will be diagnosed too late for their administration. This proposal recognizes that factors shaping everyday life, like negative views and fear of brain health disorders can profoundly delay ADRD detection among those at highest risk. In response to NIH RFA-NR-24-004, the long-term goal of this project is to address existing, and intercept a worsening of, delays in early detection and diagnosis of ADRD. To achieve our goal, we will carry out three primary objectives in partnership with local collaborators including the Allegheny County Health Department. Using the Culture-Centric Model of Health Promotion, in Objective/Aim 1 we will elicit and prioritize the voices of adults who are directly impacted by late life cognitive health disorders to create stakeholder-endorsed brain health narrative campaign materials for deployment over multimedia platforms. In Objective/Aim 2, we will use the materials developed in Aim 1 to deploy a community-focused brain health narrative campaign to combat harmful negative perceptions around brain health disorders. In Objective/Aim 3, we will assess the feasibility and acceptability of bringing state of the science AD blood-based biomarker testing infrastructure to the everyday places where persons at highest risk for ADRD live, work, shop, and play. By targeting social norms and societal level forces, this proposal addresses challenges at the NIMHD-defined community and societal levels, while, in the final aim building community based infrastructure for addressing the problem at the individual level. This approach begins by drawing upon cultural capital in the form of community members’ stories that demonstrate the value of preserving brain health or offer counternarratives about maintaining dignity through dementia. In full circle, these stories become culturally salient tools to promote accessible, early AD detection in community-based settings, bypassing the traditional healthcare systems and pathways to diagnosis that are not working for those at highest risk of disease.